Assessing vascular permeability and nanobubble extravasation with contrast-enhanced ultrasound imaging

PROJECT SUMMARY
In many chronic inflammatory diseases, vascular endothelial cells become pathologically permeable due to
conditions like angiogenesis and production of growth factors and inflammatory cytokines (e.g. histamine,
bradykinin, etc.). In cancer, this process can be exploited for delivery of nanoparticles to tumors via the enhanced
permeability and retention (EPR) effect. However, nanoparticle-based therapeutics have led to inconsistent
results in patients. This is due to many factors, with a main one being heterogeneous tumor vascular architecture
both between patients and within a single tumor. Transport of the nanoparticle to the tumor and into the
parenchyma is complicated by uptake by the immune system, ineffective margination, and inefficient
extravasation. Guidance is needed to inform clinicians on what therapies may be most effective for each patient.
Effective guidance could reduce health-care costs and negative side effects of medication. An inexpensive, safe,
non-invasive, and real-time imaging method may be capable of categorizing the extent of vascular permeability
in tumors and once validated, personalize therapeutic regimens for patients. Such a tool could be used not only
for tumors, but for all diseases involving pathologically permeable vasculature. With this goal in mind, the
objective of the proposed research in this application is to work toward development of a real-time method for
evaluating vascular permeability over the entire tumor using novel nanobubble (NB)-based contrast-enhanced
ultrasound (CEUS) in vivo. This method will build upon dynamic CEUS protocols used clinically with
microbubbles (MBs). NBs, which are 100-400 nm in diameter, have been shown to extravasate into the tumor
parenchyma. The use of clinical ultrasound in developing this method will ensure that eventual translation to
patients is safe, cost-effective, non-invasive, and widely accessible. To test this objective, Aim 1 experiments
will focus on identifying NB dynamic CEUS kinetics based on NB size and compared to MBs. It will also identify
kinetic parameters, margination, and extravasation of NBs in a flow environment in the presence of human whole
blood and permeabilized endothelium. These results will help identify the size of extravasated NBs and the
degree of endothelial permeability when applied to a more complicated in vivo setup in Aim 2. Aim 2a will use a
chick embryo chorioallantoic membrane (CAM) model with controlled levels of permeability to test NB dynamic
CEUS parameters in vivo. With known levels of permeability, the CAM results will provide essential information
for assessing the extent of permeability in vivo. This method will be applied to an uncontrolled tumor environment
in Aim 2b. This proposed research will yield: 1) new information on how contrast agent size affects interaction
with red blood cells and dynamic CEUS parameters, 2) a real-time analysis of the tumor-associated EPR effect,
yielding new physiological data, and 3) a non-invasive method for determining the extent of pathological
permeability in vivo. This proposal will provide crucial knowledge on vascular permeability and extravasation
potential of nanoparticles, which is essential to improve patient care.

Public health relevance
PROJECT NARRATIVE Many common chronic inflammatory diseases associated with heightened vascular permeability (atherosclerosis, diabetes mellitus, cancer, among others) are treated with therapeutics that are not effective for all patients, resulting in unnecessary health care costs and side effects. Currently, there is no way to safely, non- invasively, and inexpensively assess vascular permeability in individual patients. Development of a novel nanobubble-based contrast-enhanced ultrasound method for determining the extent of permeability will, once validated, provide clinicians with essential information for choosing the most effective personalized therapeutic interventions for patients.